ITAC DATA SCIENCE SUPPORT SERVICES (CIO)

Task 1: Program Management and Project Management

For the remainder of Option Year 4 (9/23/2022 – 4/22/2022), the tasks below (Task 1) shall focus exclusively on the OneStream Pilot project and not include any other projects in the ITAC or NHLBI portfolio. The Offeror may be requested to provide historical information to senior managers on previously supported programs on an ad hoc and limited basis.

Facilitate the effective management and delivery of innovative and adaptable technology

solutions by collaborating with business partners and colleagues

Gain an understanding of the business, processes, and stakeholders and aligns that understanding to the NHLBI mission

Support Federal Solution Delivery Managers (SDM), NHLBI’s IT Project Managers, Contracting Officer’s Representatives (COR), and ITAC Managers

Provide oversight of the efforts and resources across multiple NHLBI/ITAC program areas

Manage Systems Development Lifecycle (SDLC) solutions delivery processes, including Agile (Scrum and Kanban), Test-Driven Development (TDD), Continuous Integration (CI), Continuous Deliver (CD), and DevOps

Manage risks and issues in accordance with ITAC guidance

Utilize PM tools, such as Innotas and Jira, in accordance with ITAC guidance

Evaluate deliverables and make recommendations to Federal staff for acceptance of systems

Provide support to Federal and contractor staff to establish effective ITAC Program communications

Identify and translate between functional and technical requirements

Possess knowledge of enterprise IT, including Cloud computing, virtual desktops, and systems engineering, including systems development life cycle and testing

Support efforts to integrate disparate systems

Identify potential interoperability or compatibility issues

Communicate with technical and non-technical audiences, effectively

Provide SME support for implementation of integrated solutions that support the

end-to-end grants lifecycle including

Provide SME support for the integration of NHLBI grants systems with NIH

systems in order to eliminate duplicate data entry and reduce overall administrative burden

Perform the duties of a Project Manager and Subject Matter Expert (SME) for Scientific Computing

Provide SME support for implementation of systems to support the Division of Intramural Research including scientific and clinical research databases and tools

Perform the duties of a Project Manager and Subject Matter Expert on Scientific and Administrative Analytics related programs, processes, and systems

Utilize technical expertise in areas such as:

Identify and translate between functional and technical requirements

Possess knowledge of enterprise IT, including Cloud computing, virtual desktops, and systems engineering, including systems development life cycle and testing

Support efforts to integrate disparate systems

Identify potential interoperability or compatibility issues

Communicate effectively with technical and non-technical audiences

Task 2. Training and Mentoring

For the remainder of Option Year 4 (For the remainder of Option Year 4 (9/23/2022 – 4/22/2022), the tasks below (Task 2) shall be limited to the following training commitments.

Business Analysis: Understanding, Documenting, and Gaining Agreement on Your Project - Fundamentals

11/1/2022 - 11/3/2022; 11/30/2022

*or other agreed date

Process Modeling

11/17/2022

*or other agreed date

NS GS-15 Project Management

Winter 2023 (Date TBD)

Leadership lab 2.0

March 2023 (date TBD)